Methods for detecting short indels from high-throughput sequence data

DESCRIPTION (provided by applicant): In recent years, high-throughput sequencing technologies have transformed our understanding of human genetic variation by enabling the sequencing of individual human genomes as well as sequencing on a population-scale. Short insertions/deletions (indels) represent the second most frequent form of variation in the human genome, which is also functionally important. Indels have not received as much attention as single nucleotide variants (SNVs) and structural variants in part because the detection of indels from high-throughput sequence datasets is challenging and available computational methods exhibit significantly lower sensitivity and specificity compared to methods that are designed to identify single nucleotide variants. Novel computational methods that address the challenge presented by the detection and genotyping of indels are thus urgently needed. We propose to develop novel methods for the detection of short indels from both individual and population-scale sequence datasets that will utilize information about indel error rates that are specific to sequence context as well as sequencing platform from large-scale sequence datasets in order to generate accurate indel calls and genotypes. The development of these methods will significantly enhance the ability of researchers to extract accurate information about genetic variation from sequencing datasets, improve their ability to identify variants that are associated with disease susceptibility and improve our understanding of the extent and distribution of short indels in the human genome.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are developing methods for the discovery of short insertion/deletion variants, an abundant form of genetic variation in the human genome. These variants are known to affect risk for rare and complex diseases including cancers. This project will advance our ability to understand how these variants affect human health. __SpecificAimsTextDelimiter__ 2. Specific Aims The overall goal of this proposal is to develop novel computational methods for the accurate detection of short insertion/deletion variants (indels) from high-throughput sequence data. An individual human genome is estimated to harbor several hundred thousand short indel variants. Apart from being the second most common type of DNA variation in the human genome, short indels are also often functionally important, especially those found in the coding regions. Despite this, most studies of human genetic variation have focused primarily on single nucleotide variants (SNVs) and large structural variants. Accurate detection and genotyping of short indels is vital for carrying out comprehensive and meaningful analyses of high-throughput sequence data to: (a) identify genes/mutations that underlie rare diseases; (b) determine which variants are associated with risk for developing complex diseases, and; (c) discover somatic mutations that drive cancer progression. In recent years, high-throughput sequencing technologies have transformed our understanding of human ge- netic variation by enabling the sequencing of individual human genomes as well as genomes of collections of individuals. Although sequence reads generated by these technologies contain information about the presence or absence of short indels, computational methods that are currently available for the detection of this class of DNA variantion exhibit significantly lower sensitivity and specificity compared to available methods that can be used to identify SNVs. Novel, more sophisticated computational methods that address the challenge presented by the detection and genotyping of short indels are urgently needed. We propose to develop a suite of probabilis- tic methods that can be used to detect indels from high-throughput sequence data derived from individual-level or population-scale sequencing efforts. The novel feature of our approach is the pooling of information about the presence or absence of indels from multiple individuals and multiple sites across the genome. These methods will allow us to jointly infer genotypes and indel-specific sequencing error rates that are dependent on the local sequence context such as the presence of homopolymer runs surrounding the putative indel as well as errors associated with a particular sequencing technology. To develop and validate our methods, we will utilize whole-genome and whole-exome sequence datasets available at our institute as well as publicly available data from the 1000 Genomes Project. The following specific aims summarize the methods that we propose to develop and evaluate: Aim 1. Develop a probabilistic method for the detection and genotyping of short indels using sequence reads from a population of individuals by jointly modeling population genotypes and strand-specific context-specific indel error rates at each locus Aim 2. Develop a probabilistic method for the detection and genotyping of short indels using sequence data from a single individual by jointly modeling genotypes and error rates across multiple loci in the genome that share similar sequence context. Aim 3. Evaluate the accuracy of the proposed indel detection and genotyping methods using whole- genome and whole-exome sequence datasets. The methods proposed here will fill a critical gap in our ability to extract information about an important class of DNA sequence variation from large-scale whole-genome and exome sequencing projects. The development of these methods will significantly enhance the ability of biomedical researchers to extract accurate information about genetic variation from their sequencing experiments, improve their ability to identify functional variants that are associated with disease susceptibility and improve our understanding of the extent and distribution of short insertion/deletion variants in the human genome.